The role of NCOA4-mediated ferritinophagy in ozone-induced pulmonary ferroptosis.

PROJECT SUMMARY/ABSTRACT
Ground-level ozone (O3) exposure is a significant global health concern of increasing importance. Annually, an
estimated 1 million premature deaths are attributable to O3 exposure, costing the global economy billions of
dollars (USD). As global O3 concentrations continue to rise, these significant health and economic burdens are
expected to increase. O3 exposure is associated with increased morbidity and mortality of pulmonary diseases.
Thus, it is imperative to identify mechanisms by which O3 induces adverse pulmonary effects. It is understood
that acute O3 inhalation induces pulmonary injury and inflammation mediated in part by the accumulation of
airspace iron. However, what remains unclear are the mechanisms by which O3 induces this dysregulation of
pulmonary iron homeostasis and the mechanisms by which this iron accumulation mediates pulmonary injury
and inflammation. Preliminary data presented in this proposal indicate that O3 increases lung tissue gene
expression of nuclear receptor coactivator 4 (Ncoa4), which is known to facilitate the intracellular degradation of
the iron sequestering protein, ferritin. Moreover, preliminary results show that O3 reduces airspace ferritin
concentrations. Combined, these data strongly suggest that acute O3 inhalation induces pulmonary NCOA4-
mediated ferritinophagy, which may contribute to O3-induced increases in airspace iron. Additional preliminary
data reveals that O3-induced lung injury, inflammation, and cytotoxicity correspond with increased concentrations
of lipid ozonation products. Altered lipid biochemistry and increased iron concentrations are favorable conditions
for the induction of ferroptosis, a programmed cell death driven by iron overload and lipid peroxidation. Potential
for O3-induced ferroptosis is supported by preliminary data indicating O3 alters lung tissue expression of genes
associated with induction and progression of ferroptosis. Both ferritinophagy and ferroptosis have been
implicated in multiple pulmonary disease etiologies. However, it is uncertain what role these mechanisms play
in O3-induced pulmonary injury and inflammation. This proposal will investigate the hypothesis that NCOA4-
mediated ferritinophagy drives O3-induced ferroptosis and subsequent pulmonary inflammation and injury
through completion of two aims. These aims will: 1) assess the role of NCOA4 in O3-induced pulmonary
ferritinophagy; and 2) Examine the effect of cell-specific ferroptosis on O3-induced pulmonary injury and
inflammation. Completion of these aims will elucidate novel pathways in pulmonary diseases exacerbated by O3
exposure, with potential for identifying therapeutic targets. Now more than ever, this research is critical to
reducing global health and economic burdens associated with O3. Additionally, completing these aims will
support the proposed training program and provide the applicant with the necessary tools to become a successful
independent scientist researching environmental lung disease: 1) advanced laboratory techniques; 2) a strong
scientific network; 3) leadership experience; 4) scientific writing skills; and 5) ethical and collaborative research
expertise.

Public health relevance
PROJECT NARRATIVE Ozone (O3) is an air pollutant which is associated with increased morbidity and mortality of pulmonary diseases, resulting in significant global health and economic burdens. This project will define the role of NCOA4-mediated ferritinophagy and ferroptosis in O3-induced pulmonary injury and inflammation, with the goal of identifying potential therapeutic targets to prevent health effects associated with O3 exposure.